MMI-T32 Training Pre-doctoral Scientists in Molecular Microbiology and Immunology at UTSA

Abstract/Program Summary
The mission of the T32 Program in Molecular Microbiology and Immunology (MMI) at UTSA is to recruit, train
and graduate a diverse group of doctoral students in multidisciplinary areas of molecular, cell biology,
biochemistry and pathology, utilizing both microbe- and disease-focused research, while providing excellent
career development, and mentoring with the highest level of institutional commitment and support. UTSA is a
Carnegie R1/Hispanic Serving Institution with the proud distinction of awarding the second-highest number of
doctoral degrees to Hispanic students. Our specific aims include. Specific Aim 1: Provide interdisciplinary
training across areas of Host-Pathogen Interactions (HPI), Immunology (IMM), Genomics (GEN), and Disease
Intervention and Vaccines (DIV), with a rigorous curriculum and innovative, collaborative research
opportunities to a diverse group of predoctoral trainees. Specific Aim 2: Cultivate a collegial and collaborative
training environment that emphasizes belonging and developing skills in professional networking, leadership,
scientific writing, and oral communication. Specific Aim 3: Implement evidence-based approaches to enhance
recruitment, retention, and comprehensive preparation in professional development, technical skills, and
scientific rigor and design. Currently, the doctoral program trains 21 students, and the T32 program will act as
a catalyst to enhance career development, leadership, and networking, supported by diverse research
opportunities. With 25 diverse preceptors from UTSA and Texas Biomedical Research Institute, we plan to
increase UR recruitment and retention, decreasing time to degree and increasing the doctoral program's size
to at least 40 students in the next five years. Three Ph.D. students will be supported in years 1 and 2 and four
trainees in years 3-5 of the T32 grant, with institutional funding for the remainder of the training program.
Strong institutional commitment includes Graduate School support to fully fund three additional students for the
first 5 years of the program. Training in career development, responsible conduct of research, mentoring, and
health wellness are integrated within the curriculum and required activities to build rigor in research while
supporting an environment of belonging, equity, inclusivity, and science identity. Retention strategies include
frequent monitoring of student performance, open communication, constructive feedback, and team-mentoring
approaches to reach critical milestones, to be captured in the Graduate School mandated Annual
Review/Individual Development Plan. Ably mentored by internationally renowned faculty researchers, a 3-
member multiple team of faculty will provide oversight and expertise in the discipline and in building strong
professional development plans to support the success of students from diverse backgrounds. The T32
program leverages institutional resources for administrative management, with partnerships in place to provide
trainees with additional career and professional training and advising from the UTSA Graduate School, the
Career Center, Wellbeing Services, Leadership & Volunteer Services, and the Office of Research Integrity.

Public health relevance
Project Narrative We propose the MMI-T32 Program at the University of Texas at San Antonio to provide comprehensive evidence-based training and to prepare doctoral students for careers in the Molecular Microbiology and Immunology fields, including in academia and industry. As a minority-serving institution, a major focus of the program is the recruitment and retention of underrepresented students reflecting the changing demographics in the U.S.